The Functions and Mechanisms of Perceptual Learning

Project Summary/Abstract:
Research in perceptual learning has demonstrated a remarkable ability of training or practice to enhance
perception in the adult human. The last thirty years have yielded many important findings about how people
learn, what limits transfer, how generalization can be improved, how to model learning, and the nature of
visual plasticity. At the same time, learning and transfer have been measured at a relatively coarse scale that
leads to relatively inaccurate measures of learning in individuals, which could be very important to choosing
adapted training options. Related issues of estimation have also limited the types of training protocols that
have been studied. The objective of this research is to use innovative new adaptive performance assessment
(based on Bayesian principles) to provide unbiased and high precision estimates of learning in individuals. We
also use computational neural network models to generate predictions about more complicated training
regimens that are then tested experimentally. We develop a framework for searching among these predictions
computationally to identify better (optimized) training methods. The long-term goal is to develop efficient new
assessments of learning and transfer and the modeling techniques that may then be applied to improve clinical
applications, rehabilitation, and perceptual expertise identified as key aspects of the NEI mission.

Public health relevance
Project Narrative: Perceptual learning through training visual tasks can contribute to enhancing visual skills and may prove useful in remediation of some visual limitations. The current project seeks to understand perceptual learning and generalization using new rapid assessment methods, advanced statistical methods, and computational models of learning. The proposed program of model and test development and empirical testing will help to define a framework for more reliably measuring learning in individuals and predicting the efficacy of training regimens in normal adults, that could be the basis of parallel applications in rehabilitative or developmental training.